Leveraging mouse and human models to investigate neuroprotective effects of blood-derived exerkines in Alzheimer's disease

ABSTRACT
Alzheimer’s disease (AD) is an untreatable, precipitously growing public health problem. Continued failed and
equivocal trials for amyloid lowering drugs highlight the urgent need for alternative solutions to support the aging
brain and prevent AD. Physical activity is a readily available therapy associated with >30% reduced risk of
Alzheimer’s dementia; yet, how physical activity, a putatively systemic intervention, promotes brain health is not
fundamentally understood. Capturing the neurologically active mechanisms of physical activity offers an
opportunity to identify novel AD treatment targets and refine our understanding of one of the most widely
implemented behavioral interventions for brain health. This proposal builds on a recent collaboration between
Drs. Villeda and Casaletto that culminated in a publication in Science in which their teams identified a novel
blood factor, Glycosylphosphatidylinositol-Specific Phospholipase D1 (Gpld1), that mediates the neurogenic and
memory benefits of exercise in aged mice and relates to physical activity levels in humans. Gpld1 is a liver-
derived enzyme that cleaves GPI-anchored proteins from the cell surface, thereby regulating GPI-anchored
protein cascades. We observed that Gpld1 does not readily enter the brain parenchyma, suggesting an indirect
mode of action. Our preliminary mouse and human data suggest that systemic Gpld1 lowers complement and
coagulation activation, regulates GPI-anchored proteins on hippocampal blood vessels, and relates to lower
plasma complement activation and better MRI markers of cerebrovascular integrity in healthy older adults.
Together, this suggests that Gpld1 acts on immunovascular processes to support brain health. Given the early
and predominant involvement of immunovascular dysfunction in AD, we now plan to examine the neuroprotective
effects of plasma Gpld1 in AD using a cross-species design. We hypothesize that, through immunovascular
mechanisms, Gpld1 may ameliorate the neurotoxicity and propagation of AD pathology, resulting in slower
pathology accumulation and improved cognition in AD. In our Aims, we will: 1) test the longitudinal relationships
between plasma Gpld1 with physical activity monitoring (actigraphy), immunovascular, and cognitive trajectories
in 150 older adults across the AD continuum; 2) test the effect of systemic Gpld1 modulation on immunovascular
and neurodegenerative outcomes in a mouse model of AD pathology; and 3) characterize a vascular GPI-
anchored Gpld1 substrate, tissue nonspecific alkaline phosphatase (TNAP/ALPL), that has been shown to
negatively regulate blood-brain transport and be increased and inversely correlate with cognition in AD adults.
Our project is positioned to identify the utility of a novel AD therapy target that will be simultaneously tested for
causal pathways in rodent models of AD pathology and evaluated for clinical relevance in humans. Longer term,
this proposal will both facilitate our foundational understanding of how physical activity impacts brain health, and
set the stage for a potential novel clinical trial for AD.

Public health relevance
PROJECT NARRATIVE We recently identified Glycosylphosphatidylinositol-Specific Phospholipase D1 (Gpld1) as a liver-derived exerkine in blood plasma that mediates the neurogenic and cognitive benefits of exercise in aged mice and shows relevance in older adults. However, whether benefits extend in the context of Alzheimer’s disease (AD) pathology and related cognitive impairment is unknown. We now propose to test this possibility by combining mechanistic functional studies in mouse models of AD pathology with longitudinal human data in adults across the AD continuum.